Investigating the role of Wnt signaling effectors on the neuron-glia switch and OPC specification during development and after injury.

PROJECT SUMMARY
Nervous system development and regeneration relies on sequential and coordinated formation of diverse
neurons and glia from neural progenitor cells. Though neuronal and glial differentiation is extensively studied,
less is known about the molecular signals that modulate the transition from neurogenesis to gliogenesis.
Oligodendrocytes, glial cells that support axon conduction and survival through myelination, are essential for
nervous system development and regeneration. During spinal cord development, distinct neural progenitors in
the pMN domain undergo a neuron-glia switch to sequentially produce motor neurons followed by
oligodendrocyte progenitor cells (OPCs). Similarly, successful regeneration after spinal cord injury requires the
coordinated production of both neurons and oligodendrocytes to functionally restore damaged circuits. Zebrafish
are highly regenerative compared to mammals and endogenous neural progenitors produce motor neurons after
injury, but interestingly do not produce OPCs. The molecular mechanisms that regulate the neuron-glia switch
to specify neural progenitor cells into a neuronal or oligodendrocyte fate during development and after injury
remain unknown. Recently, our lab conducted fate mapping and single-cell RNAseq and revealed a molecularly
distinct subset of pMN neural progenitors, pre-OPCs, that are specified to commit to the oligodendrocyte lineage.
Our data revealed that pre-OPCs are uniquely enriched for factors involved in Wnt signaling, a cascade that
modulates OPC differentiation during development and that is reactivated after injury to regulate neurogenesis.
Using zebrafish, I will utilize immunohistochemistry and transgenic imaging techniques alongside CRISPR/Cas9
mutagenesis strategies to determine how axin1 modulates wnt expression in pMN progenitors to activate a
transcriptional switch in tcf7l2 and drive a neuron-glia switch to specify pMN progenitor cells into pre-OPCs.
Further, through powerful single-cell multi-omics techniques I will identify transcriptional interactions with
neuronal and oligodendrocyte-specific genes in pMN progenitors to establish a gene regulatory network that
drives the neuron-glia switch. Finally, I will use pharmacological and genetic tools to manipulate wnt expression
after spinal cord injury and induce a neuron-glia switch in vivo to drive gliogenesis in endogenous neural
progenitor cells. Together, these studies will uncover molecular regulators of pMN progenitor specification and
highlight the role of the neuron-glia switch in nervous system development and regeneration.

Public health relevance
PROJECT NARRATIVE The neuron-glia switch orchestrating sequential production of neurons and glia from distinct neural progenitors is essential for functional nervous system development and successful regeneration after injury. This proposal aims to identify how factors modulate Wnt signaling to regulate the neuron-glia switch and drive gliogenesis in neural progenitor cells during development and following spinal cord injury. The proposed experiments will provide insight into the molecular mediators of neural progenitor specification and emphasize the importance of the neuron-glia switch during development and after injury.